Genetic analysis of competition dependent fitness determinants in the human gut bacterium Phocaeicola vulgatus

ABSTRACT
The mammalian gut harbors complex communities of microbes that interact and compete with each other while
also influencing the physiology of the host. Discerning the mechanisms by which major members of these
microbial communities colonize the gut is a fundamentally important research goal. One major member is the
gut bacterium Phocaeicola vulgatus (Pvu), a gram-negative anaerobe and one of the most abundant bacterial
species found in the gut of humans and other mammals. Pvu has been associated with inflammatory bowel
disease and several metabolic disorders, and can also infiltrate and colonize established gut microbial
communities following a single introduction. However, there is a gap in understanding of the molecular tools that
Pvu deploys to colonize and invade established niches in the gut. Our long-term goal is to understand what
makes Pvu such an unusually efficient colonizer of the mammalian gut. Our preliminary studies have identified
an operon specific to the Phocaeicola genus that is required for fitness within the mouse gut in a manner strongly
dependent on microbial competition, but the specific functions of the genes in that operon remain unknown. I will
address this gap by defining the requirement for the genes in this operon on Pvu physiology in vitro and on in
vivo gut colonization amidst competition with other microbes. This will be accomplished through in vitro studies
involving tagging proteins encoded in the operon for immunohistochemistry, lipid binding assays, and chromatin
immunoprecipitation sequencing. Additionally, in vivo studies using germ-free and specific-pathogen free mice
will be performed to understand how the specific genes in the operon influence Pvu's colonization efficiency and
biogeography in the gut. The expected outcomes of these studies include identification of new mechanisms used
by Pvu to effectively colonize the mammalian gut as well as fundamental new insights into Pvu physiology. These
results will vertically advance the field by providing new understanding of Pvu's colonization strategies which
could eventually lead to the development of new probiotic platforms and strategies for controlling gut microbiome
composition in the context of inflammatory bowel diseases and metabolic disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of mechanisms by which microorganisms colonize the gastrointestinal tract is expected to lead to increased understanding and new treatments for human inflammatory and metabolic diseases. The proposed research is therefore relevant to the part of the NIH’s mission that pertains to developing fundamental new knowledge that will enhance health and reduce the burden of illness.